Enrichment Program

ENRICHMENT
PROGRAM SUMMARY/ABSTRACT
The goal of the New York Nutrition Obesity Research Center (NYNORC) is to advance translational research
in obesity and nutrition. This requires the development of a dynamic, cohesive and interactive community of
researchers. The Enrichment Program plays a central role in fostering this community, in which ideas,
techniques and expertise are freely exchanged. The Enrichment Program accomplishes this through weekly
meetings, special lectures, annual symposia/classes, by supporting educational efforts for students and fellows,
and helping young faculty develop research program. All of these efforts are coordinated with other programs
at Columbia and Einstein, so that there is complementarity and non-overlapping. The NYNORC holds weekly
seminars: The DeWitt Goodman Seminar Series which brings researchers from beyond Columbia and Einstein
to the NYNORC and provides a forum for local NYNORC researchers to present well developed research
projects, and the Work-in-Progress Seminar Series at which students and post-doctoral fellows present their on-
going research. The NYNORC also organizes and promotes several annual programs including the DeWitt
Goodman Lectureship, and the Obesity Course. Along with other annual programs held at Columbia and
Einstein, these longstanding programs promote the exchange of data, ideas and are aimed. All of these efforts
are designed to achieve the aims of the Enrichment Program, namely: (1) To promote scientific exchange among
NYNORC investigators (2) To facilitate the interactions between Center investigators and non-
NYNORC scientists (3) To support the education, training and development of scientists studying obesity and
nutrition.